BV-ARA-U VS ACYCLOVIR IN LOCALIZED HERPES ZOSTER IN HIV-INFECTED PATIENTS

This is a randomized, double-blind, controlled trial to compare the efficacy of BV-ara-U (800mg five times daily)in the treatment of acute, localized, non-trigeminal zoster in HIV-infected patients.